LAMICTAL IN TREATMENT OF MAJOR DEPRESSIVE EPISODE IN BIPOLAR DISORDER

Evaluate the safety and efficacy of lamotrigine compared to placebo as monotherapy for major depressive episodes in adult patients with bipolar I and bipolar II disorder. Compare the quality of life of patients treated with lamotrigine to those on placebo.